ABNORMAL PLASMA LIPID LEVELS IN PERSONS AT RISK FOR PREMATURE CHD

To investigate the genetic causes of dysplipidemia in patients with abnormal lipid levels at increased risk for premature coronary heart disease. To allow subgrouping of dyslipidemic patients based on molecular etiology, followed by statistical comparison of the subgroups with regard to lipid and apolipoprotein levels.